Mechanism of ALS/FTD determined by multimodal single cell spatial transcriptomics

PROJECT SUMMARY
Abnormal cytoplasmic accumulation and nuclear depletion of the RNA-binding protein TDP-43, collectively
referred to as TDP-43 proteinopathy, has been reported in 40% of frontal temporal dementia (FTD), 97% of
instances of amyotrophic lateral sclerosis (ALS), 50% of Alzheimer's disease (AD), and 100% of limbic-
predominant age-related TDP-43 encephalopathy (LATE). Across this disease spectrum, neurons develop
distinct stages of TDP-43 mislocalization and aggregation. A major genetic cause of FTD and ALS is a GGGGCC
(G4C2) hexanucleotide expansion in the C9ORF72 gene (C9orf72 in mice). While a normal human C9ORF72
allele has less than 20 G4C2 repeats, pathogenic repeats in disease are in the hundreds, with somatic expansion
up to 4000 repeats. There is consensus that TDP-43 nuclear loss and cytoplasmic aggregation are hallmarks of
C9ORF72 repeat expansion-mediated neurodegenerative disease. However, the precise mechanism by which
an expanded G4C2 repeat initiates pathogenesis is not established. Three primary mechanisms have been
proposed: 1) haploinsufficiency of C9ORF72 protein, 2) toxic RNA foci generated from sense and/or antisense
repeat-containing transcripts, and/or 3) accumulation of dipeptide repeat (DPR) protein products. To identify
mechanisms of pathogenesis in TDP-43 proteinopathies, we have developed a Multimodal MERFISH
(Multiplexed Error-Robust Fluorescence in situ Hybridization) approach, enabling the measurement of key
candidate proteins (including TDP-43 and DPRs) to determine cellular pathologic state while simultaneously
measuring any effect on the corresponding transcriptome. By integrating this approach with single-nuclear RNA
sequencing, our extensions allow for the determination of nearly complete transcriptomes in up to 80,000
individual cells within a single intact tissue slice. This approach preserves the critical spatial context within intact
tissue and enables correlating pathologic protein mislocalization with measurements of somatic repeat
expansion and single-cell transcriptomic RNA profiles. With this technology, we will determine which cell types
and genes are affected by TDP-43 proteinopathy, first in sporadic ALS. Next, we will extend this analysis to
C9ORF72-ALS/FTD to determine which cell types and genes are affected by repeat expansion-mediated
C9ORF72 pathological hallmarks, TDP-43 proteinopathy, as well as the presence and extent of somatic repeat
expansion. Finally, we will determine whether any genes and/or disease mechanisms are exacerbated by
reduced C9orf72 activity. By generating and examining cohorts of mice with ALS-like motor neuron degeneration
from expression of a G4C2 hexanucleotide repeat with normal, reduced, or complete absence of C9orf72 protein,
we will leverage Multimodal MERFISH to determine RNA transcriptomes in all cells as well as the presence of
TDP-43 proteinopathy, sense/antisense RNA foci, and DPR accumulation from early to late disease stages. This
analysis will determine whether, and if so how, C9orf72 loss of function affects repeat expansion-linked toxicity.

Public health relevance
PROJECT NARRATIVE A hallmark of multiple human dementias [including frontal temporal dementia (FTD), Alzheimer's disease (AD), and limbic-predominant age-related TDP-43 encephalopathy (LATE)] and the fatal, adult motor neuron disease amyotrophic lateral sclerosis (ALS) is aberrant accumulation and aggregation of the RNA binding protein named TDP-43. Across this disease spectrum, including examples of disease from inheritance of a repeat expansion within the C9ORF72 gene, affected neurons develop distinct stages of TDP-43 mislocalization. To identify disease mechanisms, we will use Multimodal MERFISH, an approach we have developed that enables identification of the nearly complete set of genes expressed in every cell within a section of normal or diseased tissue and how each of those cells reacts to cellular pathologies that develop during disease.